High-throughput optical investigation into intact large-scale nervous systems for Alzheimers disease

S`QD2+i amKK `v Hx?2BK2`’b /Bb2 b2 U.V Bb M B``2p2`bB#H2 M2m`Q/2;2M2` iBp2 /Bb2 b2 rBi? Bib mM/2`HvBM; + mb2 TQQ`Hv mM/2`@ biQQ/X Hi?Qm;? K Mv `2b2 `+? ? p2 #22M +QM/m+i2/ iQ mM/2`bi M/ Bib T i?QHQ;B+ H Q`B;BM mbBM; /p M+2/ BK ;BM; i2+?MQHQ;B2b- +m``2Mi /Bb+Qp2`B2b ? p2 K BMHv bi2KK2/ 7`QK bim/B2b QM KB+`Qb+QTB+ bvbi2Kb rBi? HBK@ Bi2/ MmK#2` Q7 +2HHbX q?BH2 BM+`2 bBM;Hv K Mv 2pB/2M+2b ? p2 BM/B+ i2/ i? i i?2 BMi2` +iBQM KQM; p `BQmb ;`QmTb Q7 +2HHb +`Qbb i?2 2MiB`2 M2`pQmb bvbi2K ?QH/b i?2 F2v iQ i?Qb2 mM Mbr2`2/ [m2biBQMb BM .- H `;2@ b+ H2 pQHmK2i`B+ BMp2biB; iBQM `2 HBKBi2/ #v +m``2Mi BK ;BM; i2+?MQHQ;B2bX 6B`bi- KB+`Qb+ H2 K2i?Q/b mb2/ BM +QMp2MiBQM H ?BbiQT i?QHQ;v- bm+? b 2H2+i`QM Q` HB;?i KB+`Qb+QTv- `2[mB`2 2ti2MbBp2 iBbbm2 b2+iBQMBM; 7Q` i?B+F b KTH2b- H2 /BM; iQ T`QHQM;2/ BK ;BM; iBK2 M/ i?2 /B{+mHiv Q7 j. `2+QMbi`m+iBQM 7`QK k. BK ;2b /m2 iQ iBbbm2 /27Q`K iBQMX PM i?2 Qi?2` 2M/- BMbm{+B2Mi bT iB H `2bQHmiBQM M/ HBKBi2/ KQH2+mH ` bT2+B}+Biv Q7 K +`Qb+ H2 TT`Q +?2b- bm+? b J_fS1hf*h- ? p2 K /2 i?2K H2bb ii` +iBp2 7Q` T i?QHQ;B+ H bim/B2bX h?mb- i?2 ;Q H Q7 i?Bb T`QD2+i Bb iQ /2p2HQT M QTiB+ H BK ;BM; K2i?Q/ i? i MQi QMHv T`QpB/2b ?B;? `2bQHmiBQM M/ KQH2+mH ` +QMi` bi bmBi #H2 7Q` i?2 T i?QHQ;v Q7 i?2 M2`pQmb bvbi2Kb BM . KQmb2 KQ/2Hb- #mi HbQ Qz2`b 2M@ #HBM; ?B;?@i?`Qm;?Tmi 7Q` i?Qb2 H `;2@b+ H2 BMp2biB; iBQMb /2K M/2/ #v K Mv Q7 iQ/ v’b . `2b2 `+?X h?Bb T`QTQb H TH Mb iQ //`2bb i?2 #Qp2 BK ;BM; M22/b #v +`2 iBM; +Q?2`2Mi QTiB+ H BK ;BM; TT ` imb iQ T`Q@ pB/2 i?2 2M #HBM; ?B;?@i?`Qm;?Tmi M/ ?B;? `2bQHmiBQM- #v /2p2HQTBM; M2r iBbbm2 T`Q+2bbBM; K2i?Q/b iQ Qz2` i?2 KQH2+mH ` +QMi` bi BM BMi +i iBbbm2b- #v #mBH/BM; +QKTmi iBQM H iQQHb iQ bbBbi i?2 #BQHQ;B+ H BMi2`T`2i iBQM Q7 BK ;BM; `2bmHibX h?2 Qmi+QK2 Q7 i?2 T`QTQb2/ `2b2 `+? Bb 2tT2+i2/ iQ #2 b2i Q7 M2r `2b2 `+? iQQHb i? i 7 +BHBi i2 H `;2@+Q?Q`i bim/B2b QM . KQmb2 KQ/2Hb rBi? #` BM@rB/2 #B;@/ i +[mBbBiBQM M/ M HvbBbX h?Bb K2MiQ`2/ T`QD2+i Bb BK2/ iQ 7 +BHBi i2 i?2 SA U.`X CB M _2MV iQ +?B2p2 ?Bb ;Q H Q7 Q#i BMBM; `2b2 `+? BM/2@ T2M/2M+2X h?`Qm;? i?2 T`QTQb2/ `2b2 `+?- i?2 SA rBHH Q#i BM +QKTH2K2Mi `v 2tT2`iBb2 7`QK ?Bb K2MiQ`b- i2 K Q7 H2 /BM; b+B2MiBbib BM+Hm/BM; .`X `2ii QmK UQTiB+ H BK ;BM;V- .`X ` /H2v >vK M UM2m`QHQ;v M/ .V- .`X a M;22i ? iB UM MQK2/B+BM2 M/ iBbbm2 2M;BM22`BM;V- .`X h vv # > b M UT?QiQ/vM KB+ i?2`@ TvV- .`X 1/r `/ Qv/2M UM2m`Qb+B2M+2 M/ QTiQ;2M2iB+bV- M/ .`X `m+2 6Bb+?H U+QKTmi iBQM H M2m`QBK ;@ BM; M/ J_AVX h?Bb +QK#BM2/ i2+?MB+ H bi`2M;i? rBHH #2 BMi2;` i2/ rBi? i` BMBM; QM + `22` /2p2HQTK2Mi bFBHH- 7 +BHBi iBM; i?2 i` MbBiBQM Q7 i?2 SA iQ M BM/2T2M/2Mi BMp2biB; iQ` BM i?2 #BQK2/B+ H }2H/X h?2 SA rBHH +QM@ /m+i i?Bb T`QD2+i K BMHv BM i?2 q2HHK M *2Mi2` 7Q` S?QiQK2/B+BM2 i J bb +?mb2iib :2M2` H >QbTBi H- r?B+? Bb bm``QmM/2/ #v b2p2` H rQ`H/@`2MQrM2/ mMBp2`bBiB2b M/ `2b2 `+? BMbiBimiBQMb BM #Qi? HB72 M/ T?vbB+ H b+B@ 2M+2bX G2p2` ;BM; i?2 bmTTQ`i 7`QK i?2 SA’b K2MiQ`b- ?2 rBHH ? p2 ++2bb iQ MmK2`Qmb `2b2 `+? 7 +BHBiB2b i i?2 ;`2 i2` +QKKmMBiv Q7 > `p `/ M/ JAhX 1MDQvBM; i?Bb ?B;?Hv KmHiB/Bb+BTHBM `v M/ +QHH #Q` iBp2 `2b2 `+? 2MpB`QMK2Mi- .`X CB M _2M rBHH mM/2`i F2 i?Bb K2MiQ`2/ `2b2 `+? M/ i` MbBiBQM iQ ?Bb `2b2 `+? BM/2T2M/2M+2X

Public health relevance
Project Narrative Alzheimer's disease (AD) is an incurable neurodegenerative disease that progressively destroys patients' cognitive functions causing enormous social and economical impact. With its underlying cause poorly understood, new imaging technologies are in demand to provide more comprehensive etiological investigation of AD over large-scale complex nervous systems, such as whole brains. In this proposal, to address this unmet need, we are to develop advanced optical imaging tools that can enable 3D brain-wide visualization of AD pathology.